TOPICAL HEXA-FLUORO 1,25-DIHYDROVITAMIN D3 IN TREATING PSORIASIS

The purpose of this study is to determine the usefulness of F6-1,25(OH)2D3 in controlling psoriasis. Two lesions will be chosen for the study, one will have F6-1,25(OH)2D3 in Vaseline, the other will receive plain Vaseline. At the end of two months, three biopsies will be taken, one biopsy of lesion treated with F6-1,25(OH)2D3, one biopsy of lesion treated with Vaseline alone, and another biopsy of uninvolved normal skin.